Admin Core

CORE A PROJECT SUMMARY
The purpose of Core A (Administrative Core) is to provide the organizational framework to optimally implement
the multi-project research program proposed in this Program Project application, a grant that seeks to understand
the unique “replication arrest” efficacy of 68-1 RhCMV-based Simian Immunodeficiency virus (SIV) vaccine
vectors as a guide to downstream clinical development of the Human Cytomegalovirus (HCMV)/ Human
Immunodeficiency virus (HIV) vectors that are currently in Phase 1 clinical testing. This framework will provide
scientific leadership and integration of the Program, as well as administrative support and assistance to the
Program Director and Project Leaders. This support and assistance includes providing logistical support on
administrative and clerical matters, facilitating interactions between Project and Core Leaders and providing a
forum for decision making, database maintenance and administration, data curation and sharing, experimental
planning, statistical analysis, regulatory compliance assistance, manuscript writing and submission, progress
report submission, and financial tracking and management, as well as organizing an external advisory committee
to evaluate the progress and overall direction of the program.
The specific aims of this Core are:
1. To ensure an interactive environment and foster a cohesive, focused relationship among Program scientists
and to provide a forum for Project and Core Leaders to set overall priorities and make key decisions via
regular meetings and videoconferences.
2. To promote scientific advancement of the Program by establishing an external advisory committee (EAC) to
review the progress of the program, and provide independent scientific and clinical development oversight.
3. To provide fiscal oversight and general administrative, budgetary, database, and statistical support for the
overall program,
4. To maintain communication with the NIAID program officer and other NIAID staff, coordinate reports to the
NIH and EAC and ensure compliance with NIH and local institutional requirements.